Administrative Core

PROJECT SUMMARY
The administrative core of the Stanford CCHI has been highly successful in the past almost twenty years in its
leadership and coordination of center activities, management of finances and resources, and facilitation of
intra-center collaboration and scientific support. The continued success of the Stanford CCHI will rely upon the
effectiveness of its administrative core. Dr. Mark Davis will remain in his role as overall Pl of the Stanford CCHI
and as the core lead for this core. He will also chair the executive committee consisting of the other project
and core leaders (Ors. Wang, Barnes, Khatri, Maecker and Chinthrajah) who will be responsible for the overall
organization, management, decision-making, and periodic evaluations within the Stanford CCHI. In addition,
they will oversee resource allocation, protection of intellectual property in conjunction with Stanford's Office of
Technology Licensing, and the involvement of other institutional resources. Dr. Jasprina Noordermeer and Ms.
Michele King will be assisting Dr. Davis to monitor overall progress, provide support to the administrative
leadership team, and coordinate center activities and collaborations. They will be joined by Dr. Molly Miranda,
who will oversee data management and sharing and upload of data to lmmPort according to the procedures
outlined in the Data Management and sharing Plan.

Public health relevance
We have assembled a broad and highly accomplished team to continue our investigations of Influenza and SARS-CoV-2 vaccination and infection, particular focusing on subjects that are vulnerable and seeking a deeper understanding of the effects of specific antibody glycosylation and specificity, bioinformatic signatures of pan virus responses and human immune organoids and the tissues and organs they interact with.